A comparative effectiveness trial of sublingual versus extended-release buprenorphine with individuals leaving a carceral setting

Abstract
Although previous research has demonstrated the effectiveness of initiating medications for opioid use disorder
(MOUDs) during incarceration, there has been very little adoption nationwide of this practice. Extended-release
buprenorphine (XR-B) is a promising intervention for the treatment of OUDs in carceral settings. Individuals
with OUDs re-entering the community are at an elevated risk for overdose and death from relapse to opioid
use among other opioid-related harms. This proposal builds on the current investigators experience conducting
clinical trials using both XR-B and sublingual-buprenorphine-naloxone (SL-B) with individuals in jail and prison.
This proposed study is a randomized controlled trial of XR-B vs. SL-B in a large metropolitan jail. An open-label
design will randomly assign 240 adults with moderate-to-severe OUDs who are soon-to-be-released from jail to
either XR-B (n = 120) or SL-B (n = 120) treatment in jail followed by 6-months of post-release buprenorphine
treatment, a 7-month safety visit, and final long-term follow-up at 12-months. The study has three aims: Aim 1.
Compare the effectiveness of XR-B vs. SL-B in terms of: Primary Outcome. (a) illicit opioid use (i. urine
toxicology; ii. self-reported days of opioid use using Timeline Followback; and iii. time to opioid relapse).
Secondary Outcomes. (b) retention in buprenorphine treatment (i. days receiving buprenorphine and ii. time to
treatment dropout); (c) other illicit substance use (i. urine toxicology; ii. self-reported days of illicit substance
use using Timeline Followback; (d) overdose events (non-fatal and fatal); (e) quality of life (i. physical health; ii.
mental health); (f) HIV risk behaviors (i. sexual risk behavior; ii. needle use or sharing); and (g) criminal activity
(i. crime days; ii. re-arrest; iii. technical violations; iv. re-incarceration). Aim 2. To calculate the cost to the state
and/or jail/city health system of implementing XR-B and SL-B, and determine the relative value, including the
costs associated with the interventions in the community, from a county and state-policymaker and societal
perspective. Aim 3. Explore barriers and facilitators to XR-B/SL-B implementation in jail: (1) dose induction; (2)
diversion and procedures for reducing diversion; (3) continuity of care after release or transfer to another
facility; (4) staffing (both custody and medical) needs for daily versus XR-B buprenorphine dosing; and (5)
patient preference for XR-B versus SL-B. The proposed study would be innovative because it would be the first
large scale RCT in the US assessing effectiveness and cost effectiveness of XR-B versus SL-B with individuals
in a jail who are re-entering community. Understanding how to expand acceptance of buprenorphine in jails,
has far-reaching implications for expanding treatment access in jail.

Public health relevance
Project Narrative The proposed study will be the first large scale RCT in the US assessing effectiveness and cost effectiveness of XR-B versus SL-B with individuals in a carceral setting who are re-entering community. The study will be significant because most individuals with OUD do not receive buprenorphine treatment while in jail, thereby substantially raising their likelihood of relapse to drug use, overdose death, and re-incarceration when they are released. Finally, understanding how to expand acceptance of extended-release and sublingual buprenorphine in jails, has far-reaching implications for expanding treatment access in this population.